A Low-Cost, High-Access Intervention to Increase Intention to Change Alcohol/Tobacco Use Among Reticent Veterans who are Non-Responders to Brief Advice at High Risk Due to Chronic Conditions

Background: Chronic diseases are prevalent, costly, and have been linked to increased risk of mortality and
morbidity in Veterans. Hazardous alcohol use and cigarette smoking can significantly exacerbate these
negative consequences for Veterans. To help mitigate risk, VHA primary care health initiatives have prioritized
hazardous alcohol use and cigarette smoking and have mandated that patients be annually screened and
receive a brief intervention (primary care intervention delivered by the patient-aligned care team; PACT) if
positive. However, many Veterans continue to smoke and/or hazardously drink. Current VHA treatment options
do not meet the needs of these reticent Veterans. Motivational Intervention Designed for Self-management and
EducaTion (MINDSET) is an evidence-based, remote, low-resource intervention that uses a motivational
approach to increase change intentions within the context of their chronic disease.
Significance: Most healthcare costs come from Veterans with chronic diseases (e.g., cardiovascular disease;
CVD), which are worsened by hazardous alcohol use and smoking. This research addresses multiple VHA
priorities through its focus on increasing access to care for a subgroup of reticent Veterans with chronic
disease. MINDSET’s integrated focus on smoking and hazardous drinking in the context of chronic disease
management aligns with Veteran’s priorities, and diabetes and CVD were a top ranked health concern by
Veterans. This work is also very well aligned with several HSR&D Priorities, including Complex Chronic
Disease Management, Mental & Behavioral Health, Equity, Women’s Health, Aging, and Access to Care.
Innovation & Impact: MINDSET’s design, which recognizes the competing demands within medical settings
and the inequities of underrepresented groups (i.e., woman, minorities, older adults), intentionally utilizes
universal and accessible dissemination methods (e.g., mail and telephone) to decrease burden while
increasing reach and impact. This study uniquely fills a gap in VHA and HSR&D research as there are no
evidence-based interventions tailored for this subgroup of reticent Veterans who smoke and/or drink above
recommended limits and have co-occurring CVD, cardiac risk factors, and/or diabetes. The impact potential is
high, as moving this subgroup of reticent Veterans toward changing smoking/hazardous drinking will
dramatically decrease their health risks and healthcare costs.
Specific Aims: The proposed work will: 1) evaluate MINDSET+usual care (UC) in comparison to UC alone
(brief PACT advice) on precursors to change (i.e., behavioral control, intention to change), and substance
consumption, 2) assess longitudinal interrelationships between consumption, precursors, and other distal
outcomes and 3) optimize the research activities within the trial to preliminary implementation outcomes .
Methodology: We will conduct a type 1 hybrid effectiveness-implementation RCT, where enrolled Veterans
will be randomized to either the intervention condition UC (i.e., PACT brief advice) alone or (usual care
[UC]+MINDSET). To increase generalizability to the target end users (i.e., Veterans with chronic diseases), we
will use a sampling scheme to increase our representative of specific subgroups with noted disparities in these
areas of research: minorities, women, and older Veterans. Assessments will occur every 4 weeks, with
comprehensive assessments every 3 months for one year. We will utilize a stratified block randomization
method based on whether Veterans report only smoking, only hazardously drinking . Our primary outcome will
assess participants’ intention to change each behavior separately, and a total summed score across items
divided by the number of items endorsed (based on behaviors engaged in) will be utilized to summarize their
overall intention to change.
Next Steps/Implementation: If MINDSET is effective, additional implementation research/efforts will be
proposed. Results will be disseminated on PCMHI, PACT, and other CoP calls as well as on the CIH website.

Public health relevance
Many Veterans who have chronic conditions smoke or drink too much alcohol, which can worsen the condition. Veterans are asked yearly about drinking/smoking and providers provide a brief advice discussion focused on behavior change. However, many Veterans continue to drink or smoke, and are often not interested in higher- intensity, change-based referrals. We recently piloted MINDSET, an intervention that fills this gap. MINDSET is a proactive, population-based intervention that uses a mailed packet with tailored education about how drinking/smoking relate to the Veteran’s condition (heart conditions and/or diabetes), followed by a brief motivational call. We will test MINDSET’s effectiveness versus usual PACT care on outcomes including intention to change and substance use and evaluate the relationships between these and other variables over time while ensuring representation from subgroups of older, minority, and women Veterans. We will also interview providers and leaders about how to best implement MINDSET in the future.